Manipulation of Tumor Specific Immunity

The long-term objective is to use animal models to find mechanisms and approaches whereby adoptively
transferred T cells transduced with mutant neoantigen-specific TCRs can eradicate solid cancers in patients
without destroying normal tissues. Tumors in patients have been present at least for months or years and are
usually at least 1cm in diameter at time of diagnosis. Therefore, large and long-established solid tumors
expressing autochthonous (untransfected) mutant neoantigens are the focus of this proposal. A key element
being explored is the destruction of the immunosuppressive stromal tumor microenvironment by transfer of
MHC Class II restricted neoantigen-specific TCR-transduced CD4+ T cells (CD4+TCR). These T cells cause
tumor destruction followed by long-term arrest of tumor growth. A second key element being explored is that
CD4+TCR T cells form 4-cell-type clusters with MHC Class I restricted neoantigen-specific TCR-transduced
CD8+ T cells (CD8+TCR) which are attracted to the cluster by recognizing the cross-presented neoantigen on
stromal CD11b+ tumor-associated macrophages. Finally, intraclonal non-heritable heterogeneity is explored as
novel mechanism of escape of cancers despite cancer cells seemingly lacking mutant neoantigen-negative
variants. Aim 1 is to determine the requirements and mechanisms for CD4+TCR T cells to destroy, without
CD8+ T cells, advanced solid tumors and subsequently arrest their growth. It will be tested whether targeting
tumor stroma is essential for this CD4+TCR-mediated destruction/arrest and whether these effects are
independent of direct cancer cell recognition. Furthermore, it will be examined whether therapeutic CD4+TCRs
can be isolated from tumor-infiltrating lymphocytes (TILs) that are failing to reject the cancer. Finally, it will be
tested whether appropriate lysosomal processing of mutant neoantigen is a decisive predictor for CD4+TCR-
mediated tumor destruction. Aim 2 is to determine whether 4-cell-type clusters at the effector phase are
essential for cancer eradication by CD4+TCRs and CD8+TCRs. It will be analyzed whether direct cancer cell
recognition by the CD8+TCR is required for cancer eradication. Furthermore, it will be tested whether, for
synergistic cancer cell destruction, the two neoantigens must be released from the same cancer cell because
this would allow the CD8+TCR T cells to recognize the cross-presented neoantigen on the same CD11b+
stromal cell also being recognized by the CD4+TCR T cells. Antigen-specific 4-cell-type cluster formation will
be quantified and modeled in vitro using longitudinal time-lapse imaging. Finally, will be determined whether
cancers brought into equilibrium by CD4+TCRs can still be eradicated by subsequent treatment with CD8+TCR
transduced T cells. Aim 3 is to determine mechanisms of escape and the molecular nature of CD8+TCR
recognized antigens that can be used to eradicate cancers in synergy with CD4+TCRs. It will be examined
whether cloned cancer cells seemingly lacking antigen-negative variants nevertheless escape by the presence
of cancer cells with low mutant mRNA expression due to intraclonal heterogeneity.

Public health relevance
The long-term objective is to develop therapeutic approaches for mutation-specific TCRs to eradicate cancer in patients. The immediate objective is to utilize in vitro assays and animal models that mimic human cancers in order to maximize translational potential. Results obtained by experimentation in animals will suggest new approaches and provide a blueprint for making mutation-specific TCR treatment effective in humans with advanced tumors.